Epithelial-mesenchymal crosstalk in intestinal polyp formation

Project Summary Epithelial-mesenchymal interactions within the mammalian small intestine regulate stem cell
dynamics for accurate balance between cell proliferation and differentiation. Mesenchymal cells, particularly
fibroblasts, secrete signals to regulate epithelial cells, such as Wnt for epithelial growth and Bmp for epithelial
differentiation. However, how fibroblasts themselves are regulated remains unknown. Studying fibroblast biology
is critical, as fibroblasts can drive intestinal polyposis, which is a common gastrointestinal condition with epithelial
hyperproliferation linked to elevated risk of intestinal carcinogenesis. Human juvenile polyposis and hereditary
mixed polyposis syndromes are associated with germline mutations that lead to Bmp signaling loss. Despite
common feature of epithelial overgrowth in polyps, mouse studies have demonstrated that specific loss of Bmp
signaling from fibroblasts, not from intestinal epithelium, is sufficient to drive polyp formation. The mechanisms
by which Bmp signaling loss from fibroblasts drives uncontrolled epithelial growth in developing polyps remain
unclear. The overall objectives are to (i) determine the underlying fibroblast-driven mechanisms of epithelial
hyperproliferation upon Bmp signaling loss in Aim 1, and to (ii) define the role of Bmp signaling to fibroblast
identity specification and maintenance in Aim 2. To induce polyp formation, an inducible Bmp signaling loss-of-
function mouse model through overexpression of the Bmp antagonist Noggin is utilized. Strikingly, within three
days of Bmp signaling inhibition, the intestine first undergoes an architectural change, an ectopic tissue fold, that
does not involve epithelial hyperproliferation. Rather, epithelial proliferation only increases after several weeks
of Bmp signaling loss. My finding is the first to suggest the role of tissue architecture in regulating stem cell
dynamics and epithelial homeostasis. The central hypothesis is that alterations in specific subset(s) of intestinal
fibroblasts disrupt local tissue architecture, resulting in polyp formation. The long-term goal is to understand how
spatially segregated, unique fibroblast subtypes regulate tissue homeostasis and contribute to disease
pathogenesis. As my preliminary data demonstrate that fibroblasts mislocalize and accumulate towards stem
cells, coinciding with ectopic fold formation, Aim 1 will examine changes in fibroblast-secreted Wnt ligand
distribution within the epithelium, and whether these changes result in epithelial overgrowth in developing polyps.
This aim will deepen our foundational knowledge on dysregulated crosstalk between epithelial cells and niche
players in intestinal pathogenesis. Aim 2 will employ a spatial transcriptomic approach to examine the effects of
Bmp signaling loss to fibroblast gene expression profiles and localization during polyp initiation and progression.
It will reveal the requirements for Bmp signaling in specifying/maintaining fibroblast subtype identity and spatial
distribution in intestinal homeostasis, and that when disrupted, drives epithelial hyperproliferation in developing
polyps. Completion of this project will advance our knowledge on fibroblast regulation and stem cell niche
dynamics, which could lead to the identification of novel target cell types in preventing/treating intestinal cancers.

Public health relevance
Project Narrative Epithelial-mesenchymal crosstalk tightly regulates the balance between cell proliferation and differentiation to sustain the frequent cellular turnover needs of the mammalian small intestine. While mesenchymal cells, particularly fibroblasts, function to support stem cells, fibroblasts have unexpected pathogenic roles that drive uncontrolled epithelial growth in intestinal polyp formation. This project is relevant to public health as it will reveal the underlying fibroblast-driven mechanisms in polyp formation and deepen our foundational knowledge on dysregulated epithelial-fibroblast crosstalk in disease initiation, which could ultimately lead to the identification of novel target cell types in preventing/treating intestinal cancer and other fibroblast-mediating diseases.